Long noncoding RNA regulations in breast cancer among African-American women

ABSTRACT
Breast cancer rates among African-American (AA) women continue to rise and may further widen breast
cancer disparities experienced by AA women, who are more likely to develop aggressive tumor types with a
worse prognosis. The biological reasons for these differences remain largely unknown. Recent genome-wide,
high-throughput studies highlight an emerging role of long noncoding RNAs (lncRNAs) as a novel class of
regulatory molecules in cancer. LncRNAs form an important regulatory layer in global gene expression, and
increasing evidence indicates that abnormal expression of specific lncRNAs can contribute to breast cancer
carcinogenesis and progression. Studies to date, however, are focused exclusively on EA women, have not
commonly used high-throughput next generation sequencing (NGS) to provide unbiased comprehensive
profiling, and mostly do not incorporate rigorous normal tissue controls. Motivated by these research gaps and
limitations, we recently completed a pilot study of genome-wide lncRNA expression profiling in normal and
tumor breast tissues from AA and EA women. LncRNA expression data showed clear tissue- and subtype-
specific expression patterns. Importantly, we noted a number of differentially abundant lncRNAs between AA
and EA women by estrogen receptor (ER) status. These results indicate that there are unique lncRNA
expression patterns in AA tumors, which we hypothesize contributes to aggressive tumor biology and high
breast cancer-related mortality. We propose a cost-effective study in a well-characterized cohort of AA breast
cancer patients in the Women’s Circle of Health Study (WCHS), which has available tumor tissue blocks, and
extensive data on tumor characteristics, clinical outcomes, treatments received, lifestyle factors, and genome-
wide DNA methylation. As such, our Specific Aims are: 1) Perform tissue lncRNA expression profiling using
total RNA sequencing (1181 AA cases from WCHS and 100 AA controls from Komen Tissue Bank) to
determine lncRNAs that are breast cancer- and ER subtype- specific (tumor, ER+, ER- vs. normal) and those
associated with clinico-pathological factors (e.g., grade); 2) Examine associations of lncRNA expression levels
with breast cancer survival, and use a machine learning approach to identify a combined panel of lncRNAs
associated with breast cancer survival; and further perform computational prediction and in vitro functional
assays to determine their biological relevance; and 3) Integrate paired data on lncRNA expression and DNA
methylation to determine which of these cancer- and prognosis-relevant lncRNAs are regulated by DNA
methylation, and explore whether diet, obesity and other lifestyle-related factors are associated with aberrant
DNA methylation. This work is novel and findings are anticipated to advance our understanding of molecular
mechanisms contributing to aggressive tumor biology and poor cancer prognosis observed in AA women that
can be translated into the development of targeted strategies for prevention and therapeutics.

Public health relevance
PROJECT NARRATIVE (PUBLIC HEALTH RELEVANCE) African American (AA) women have a higher risk of being diagnosed with aggressive breast cancer and have the highest mortality rate among all racial groups in U.S. women. We will systematically elucidate the role of long noncoding RNAs (lncRNAs), a novel class of regulatory molecules, in breast cancer prognosis in AA women. This work is new and is anticipated to advance our understanding of molecular mechanisms contributing to the aggressive tumor biology and poor cancer prognosis observed in AA women.